RCT to Improve Post-Hospital Treatment Adherence for Comorbid Substance Use and Bipolar Disorders

There is a substantial co-occurrence between substance use disorders (SUDs) and bipolar disorder. This
comorbidity pattern is associated with a host of negative outcomes. The co-occurrence of SUDs and bipolar
disorder is related to even poorer adherence rates, and nonadherence is a consistent predictor of negative
outcomes. The transition from psychiatric hospitalization to outpatient care is a time of heightened risk in this
population for nonadherence, substance relapse, and suicidality. To date, there is very little research on
effective and feasible behavioral interventions designed to improve treatment adherence and engagement in
this high-risk, comorbid population at the critical period following hospital discharge. Supported by a previous
treatment development grant from NIDA, we developed a novel psychosocial intervention as an adjunct to
treatment as usual, designed to reduce substance abuse, nonadherence, mood symptoms, and other clinical
outcomes among high-risk patients with co-occurring SUDs and bipolar disorder. This intervention, called the
“Integrated Treatment Adherence Program” (ITAP), is an innovative approach that combines brief in-person
engagement sessions with follow-up phone sessions and family/significant other involvement, as an adjunct to
treatment as usual over 6 months post-discharge. Pilot data on the ITAP intervention have been quite
promising, showing faster and larger improvements in outcomes such as drug days using, mood symptoms,
and adherence compared to treatment as usual. However, further testing is needed to confirm the efficacy and
feasibility of delivering ITAP in typical clinical settings. The present project is designed to meet the objectives of
Stage II treatment development research (PA-18-055). We propose to conduct a fully-powered clinical trial
evaluating ITAP by randomly assigning 160 patients with comorbid SUDs and bipolar disorder, initially
recruited during a psychiatric hospitalization and followed after discharge, to either the ITAP intervention or a
Safety Assessment and Follow-up Evaluation (SAFE) comparison condition, both delivered as adjuncts to
community treatment as usual. We will train master's level hospital therapists to deliver ITAP/SAFE and
measure therapist fidelity to the intervention. We will conduct blind follow-up assessments at 3 (mid-treatment),
6 (post-treatment), and 9 month follow-ups. We hypothesize that, compared to those receiving SAFE, patients
assigned to ITAP will have fewer days using drugs, lower mood symptoms and suicidality, and higher rates of
adherence to psychiatric and substance abuse medications (based on electronic monitoring) at post-treatment
maintained through follow-up. We also will test whether the proposed mechanisms of ITAP (greater treatment
adherence, values-action consistency) mediate substance use and other clinical outcomes, as well as test
potential moderators of outcomes (substance type, gender, baseline mood episode). When completed, this
study will fill an important clinical gap by evaluating an intervention to “bridge the gap” for comorbid SUD and
bipolar disorder in the context of transition from hospital to community care, when patients are at highest risk.

Public health relevance
Narrative We expect that this clinical trial will provide evidence that the Integrated Treatment Adherence Program (ITAP) is an acceptable, safe, and efficacious adjunctive treatment for patients with comorbid substance use and bipolar disorders following hospital discharge, when risk is highest for these patients. ITAP has the longer-term potential to fill an important gap in current clinical practice by improving the transition from inpatient to community care, thereby reducing long-term morbidity and mortality associated with relapse, nonadherence, and suicidality.